Dissecting the logic of mammalian gene regulation using synthetic biology and single-cell sequencing

PROJECT SUMMARY
During development, a series of extracellular signals lead to the formation of different cell-types by inducing the
differential expression of many genes. Although all genes experience the same signal, the expression of some
genes is increased, some reduced, and others stay the same. Therefore, the gene expression profile that is
characteristic of any cell-type must result from each genomic locus interpreting the signal in a distinct manner.
The loss of faithful signal interpretation by genomic loci is pathogenic in many contexts including cancer and
neuropsychiatric disease. Thus, an understanding of how individual genomic loci interpret extracellular signals
is a fundamental yet unresolved problem. The challenge in understanding cis-regulation in response to
extracellular signals is two-fold. First, any manipulation of the signal (concentration, duration, identity) leads to
myriad pleiotropic effects in trans that confound interpretation. Second, multiple cis-regulatory elements
(CREs) work together across large genomic windows to specify the expression of their target gene. Even in
this post-CRISPR era, it has remained challenging to simultaneously manipulate multiple CREs across these
large genomic regions to deconvolve their relative contributions to target gene regulation. This proposal seeks
to solve these challenges using a combination of synthetic biology and single-cell sequencing.
At the HoxA cluster, extracellular signals such as retinoic acid (RA) and Wnt induce the establishment of
distinct transcriptional, epigenetic and topological domains that are stably inherited through cell divisions. In
Aim1, we will rewire the HoxA cluster to respond to an extracellular signal that is completely orthogonal to the
rest of the genome. This will enable the independent manipulation of transcription factor binding in cis and
changes to the trans-regulatory environment to determine their relative contributions in establishing and
maintaining the HoxA response to differentiating signals.
We are unlikely to glean generally applicable principles of gene regulation from studies of a single locus. In
Aim2 we will develop a technology that uses single-cells as individual experiments to massively increase the
scale at which interactions between CREs can be uncovered at any locus. This technology will be applied to
dissect the regulatory landscapes of genes involved in neuronal cell-type specification. We will then use the
large dataset to develop a predictive model of cis-regulation at other loci.

Public health relevance
PROJECT NARRATIVE The precise control of gene expression is crucial for the faithful orchestration of the developmental program, but mis-expression of genes can be pathogenic in many contexts. The proposed work will combine advances in large-scale DNA synthesis and single-cell sequencing to study the regulation of genes that pattern the developing nervous system, but are also implicated in diseases such as Alzheimer’s and cancer. Therefore, the results of this project will reveal fundamental principles of development but will also inform disease mechanisms and potential therapies.